Development of Haloperoxidase Enzymes for New Applications in Chemical Synthesis

ABSTRACT
Halogenation is a chemical reaction that is responsible for the introduction of a halogen atom including chlorine,
bromine, iodine and fluorine (Cl, Br, I, F) into an organic compound. It has emerged as one of the most important
reaction types for the selective synthesis of pharmaceuticals and biologically active compounds and for late-
stage functionalization of drugs to enhance their therapeutic properties. Despite the importance of halogenation
in drug development, current methods are largely reliant on reagents that are air- and moisture-senstive and/or
unselective in the halogenation event, leading to the production of undesired halogenated byproducts. Enzymes
are an attractive catalyst option for performing halogenation and halogenation-mediated reactions because of
their unmatched selectivity and sustainability parameters. The overarching goal of my research group is to
discover and develop halogenating enzymes for perfoming selective halogenation or halogenation-mediated
reactions for chemical synthesis. Among the broad range of halogenase enzymes in nature, the vanadium-
dependent haloperoxidase (VHPO) class of enzymes have been recognized as an attractive option for
halogenation in chemical synthesis. These fascinating enzymes perform halogenation using inert halide salts
and hydrogen peroxide as the terminal oxidant. Some additional notable features of VHPOs are their ease of
access, tolerance to a broad range of solvents and temperatures and their ability to act on a wide range of
substrate types. Over the next 5 years, the central goal of our research team is to expand the synthetic
capabilities of this enzyme class in both halogenation-mediated and halogenation reactions for downstream
application in the synthesis of biologically active compounds. In our first approach (Thrust A), we will use a
concept referred to as enzymatic halide recycling to perform new biocatalytic oxidation and bond forming
reactions. In this approach, a catalytic quantity halide salt is repeatedly oxidized by the enzyme to faciliate new
bond formation using hydrogen peroxide as the terminal oxidant. In our second approach (Thrust B), we will
develop a series of defunctionalative halogenation (replacing a functional group with a halogen) and
halooxidation (addition of a halogen and an oxygen atom) reactions. Collectively, these approaches will provide
a sustainable and selective catalyst platform for accessing intermediate and target compounds that are relevant
to drug discovery and also dramatically expand the synthetic repertoire of halogenase enzymes for chemical
synthesis.

Public health relevance
PROJECT NARRATIVE Halogenation is one of the most important chemical reactions in drug discovery and development but traditional methods are largely unselective. This proposal will develop vanadium-dependent haloperoxidase (VHPO) enzymes as a selective biocatalyst platform for halogenation and halogenation-mediated transformations.